Community Engagement Core

Community Engagement Core
SUMMARY
The overarching goal of the Community Engagement Core “is to develop, enhance, and
strengthen relationships and partnerships with our community-based organizations in the
Gadsden and Leon County African American communities to create a sustainable research and
outreach environment for eliminating cancer disparities. Over the years, the College of Pharmacy
and Pharmaceutical Sciences has developed strong collaborative relationships with community
organizations in Leon County and Gadsden County through various community-based
participatory research projects. Previous partnerships established in both counties provided
breast cancer screening through free mammograms for over 600 underserved women. The CEC
core leaders and community advisors have additional partnerships on several racial disparity
issues such as infant mortality, diabetes, cardiovascular disease and HIV/AIDS. For the
Community Engagement Core, a community advisory council will be established to provide an
active role in the recruitment of participants, planning of community events/activities, health
education and research dissemination. As part of our community-based participatory approach,
three community advisors and other stakeholders have been identified to participate actively in
community outreach activities. Additionally, classroom lab experiments based on real-world
applications will engage student interest in biomedical science through hands-on learning. In
cooperation with three high schools, interested students will also be offered one-on-one mentoring
opportunities with RCMI FAMU scientists.
Relevance to Public Health
Utilizing community-based outreach efforts to understand and address cancer risks as well as
increase cancer screening among African American men and women can eliminate the
disparities in cancer treatment and mortality for this high-risk population.